Modulation of the migratory dendritic cell tumor-immune microenvironment as a novel treatment for SMARCA4-mutant lung adenocarcinoma using combined anti-ICAM1 and anti-PD-L1 therapies

Abstract:
Disease progression/ metastasis is responsible for over 90% or 100,000 deaths in patients diagnosed with lung
adenocarcinoma (LAD). Metastasis suppressor 1 (MTSS1) is a metastasis suppressor protein critical for
maintaining cell cytoskeletal integrity. Its role in lung adenocarcinoma pathogenesis is largely unknown. We have
shown that loss of MTSS1 expression is correlated with poor survival in lung adenocarcinoma patients and that
re-expression of MTSS1 inhibits in-vivo metastasis. Our recent investigation has demonstrated MTSS1
expression is critical for disease progression in SMARCA4-mutant LAD, an aggressive subtype of lung
adenocarcinoma with no targeted therapies. In this proposal, we will characterize a novel mechanism and
targetable pathway mediated by MTSS1 in SMARCA4-mutant lung adenocarcinoma. Using whole transcriptome
sequencing/pathway analysis, we have discovered MTSS1 expression decreases myeloid cell tumor
microenvironment pathway gene expression in SMARCA4-mutant LAD. We have discovered a novel
mechanism by which MTSS1 inhibits NF-κB activity in SMARCA4-mutant LAD. ICAM1 was the most significantly
downregulated protein by MTSS1 in SMARCA4-mutant LAD and is an important surface marker of the
metastasis phenotype in SMARCA4-mutant LAD. Our preliminary in-vivo studies showed that anti-ICAM1
blocking antibody reduces disease progression in SMARCA4-mutant LAD and also upregulated migratory
dendritic cell population in the tumor microenvironment. Migratory dendritic cells are robust tumor antigen
presenting cells that also upregulates PD-L1 expression in the tumor microenvironment. Aim 1 will evaluate the
synergistic effect of anti-ICAM1 and anti-PD-L1 therapy on SMARCA4-mutant LAD using an immunocompetent
CD34+ humanized orthotopic mouse model. Aim 2 will further characterize the alterations of myeloid cells within
the tumor microenvironment as well as the single cell gene transcriptional changes following this novel combined
therapeutic approach in SMARCA4-mutant LAD. The novel treatment strategy proposed could provide an
effective therapy for a lung adenocarcinoma subtype which is resistant to currently available treatments.

Public health relevance
Project Narrative: Lung cancer is the leading cause of cancer-related death in the United States. Over 90% of patients with lung cancer die from the disease spreading to other organs. The proposed study will focus on a novel mechanism and pathway in a specific genetic subtype of lung adenocarcinoma that is lethal and currently has no targeted therapy. Using human lung cancer cells and tissue, we will learn how this new pathway prevents lung cancer from spreading to other sites and we will apply this knowledge to develop a new treatment to prevent cancer spread. The knowledge gained through this study will increase our understanding of how lung cancer progresses and provide a new targeted treatment for patients with a gene-specific mutated type of lung cancer.